Developmental Biology Training Program

Developmental biology, an interdisciplinary science at the leading edge of modern biomedical research, integrates stem-cell and molecular biology, genetics, biochemistry and whole-animal model systems. This Developmental Biology Training Grant (DBTG) application requests support for nine predoctoral and three postdoctoral trainees in an interdepartmental Developmental Biology Training Program, consisting of individualized research training under the guidance of 33 faculty members in seven PhD degree-granting departments at the University of Utah. The Internal Advisory Board (IAB) selects Trainees through a formal application process and NIH study section-style review. Predoctoral Trainees who have completed their qualifying exams in the Biosciences Programs or the MD/PhD Program are supported for up to three years, while Postdoctoral Trainees are supported for up to two years. Both groups are selected from a highly competitive pool, based on excellence in previous research, a research proposal, and letters of recommendation. This Program uses ten mechanisms for value-added training of these carefully chosen and especially competitive Predoctoral and Postdoctoral Trainees: twice-monthly Developmental Biology Discussion Group meetings; didactic coursework focused on Developmental Biology and science ethics; DBTG Sponsored Seminars; experience in hosting visitors and national Symposia; funding and preparation for Trainee presentations at national scientific conferences; training in the effective utilization of Predoctoral and Postdoctoral Individual Development Plans (IDPs); unique Postdoctoral Mentoring committees that add significant guidance to each Postdoctoral Trainee’s career development; an innovative Mentor-the-Mentor program that enhances the faculty’s ability to mentor Trainees; opportunities for Grant/Fellowship Writing Workshops; and a highly successful DBTG Annual Retreat. The Program actively solicits and implements recommendations from Trainees, Mentors, IAB and External Advisory Board (EAB). With leading researchers in multiple model organisms, this Program has an exceptional track record of training predoctoral and postdoctoral scientists in the interdisciplinary field of Developmental Biology, and preparing them to direct their own first-rate independent research programs.

Public health relevance
Project Relevance to Human Health: Developmental biology is an interdisciplinary science, incorporating cell and molecular biology, genetics, biochemistry and bioinformatics in whole-animal model systems at the leading edge of modern biomedical research. Training predoctoral and postdoctoral researchers in developmental biology provides the next generation of biomedical researchers with experience in a wide range of model systems for important discoveries in human health and disease.